Imaging Mobile Zinc Biology

DESCRIPTION (provided by applicant): Zinc mobilized from endogenous stores serves as a signaling agent in the brain, pancreas, prostate, and other organs. In the central nervous system, high concentrations of mobile zinc of poorly defined function are heterogeneously distributed throughout the brain. Elucidating mobile zinc neurobiology requires sophisticated probes that selectively report its time-dependent location and concentration within live cells, tissues, and animals. The invention and application of luminescent probes allow one to track the spatiotemporal properties of mobile zinc, providing insight into its functions. This proposal delineates strategies for generating advanced fluorescent zinc sensors that overcome the limitations of current probes, mainly pH sensitivity, adventitious localization, and an inability t operate effectively in the near-infrared (NIR) region. The first aim is to install zinc- reactive esters onto the fluorophore scaffold to greatly improve the dynamic range, pH profile, and targetability of the sensors. Esterified probes can be made impervious to unwanted proton- or esterase-induced turn-on, rendering them essentially non-fluorescent, and can be delivered to discrete locales in live cells. Zinc-promoted de-esterification restores fluorescence, generating a bright, Zn-selective signal. In the second aim, a related but distinctive strategy will provide mobile zinc sensors that operate at long wavelengths required for deep tissue penetration. Zinc-induced fluorescence will be generated by promoting a major change in molecular structure of a probe from a dark form to an emissive, extensively conjugated isomer via ring-opening of benzooxazinoindoles and related molecules. The resulting chemistry will generate red and NIR fluorescent products in a reversible, pH-insensitive, and biocompatible manner. With these new reaction-based sensing mechanisms, the first two aims address the issues of dynamic range, pH-sensitivity, and imaging depth that have limited progress in mobile zinc sensing. The third aim introduces peptide- and protein-based targeting vectors that localize small-molecule zinc sensors to discrete subcellular locales. This strategy overcomes uncontrolled localization inherent to existing small-molecule fluorescent probes and provides spatial information not available via optical microscopy by limiting turn-on only to situations where Zn2+ arrives at a programmed target. These platforms also offer access to ratiometric sensors with variable zinc-binding fluorophores to tune their Kd and emission wavelength, as well as access to localization modules. The final aim applies the foregoing novel constructs to address the action of mobile zinc in neural progenitor cells and sensory circuits. With sensors at programmed cellular locales, changes in zinc pools during neural progenitor cell differentiation will be determined. Through collaborations, targetable, reaction-based probes will be applied in live tissues and animals to help elucidate the functions of mobile zinc. Because the strategies outlined here can be applied to visualize analytes apart from zinc, they will impact other research areas in neurochemistry and offer fundamental insights into the physiology and pathology of metals in the brain.

Public health relevance
PUBLIC HEALTH RELEVANCE: Mobile forms of zinc are thought to play critical roles in the physiology of memory formation, the differentiation of neural stem cells, and the processing of sensory information. When mobilized in an uncontrolled manner, for example during optic nerve damage, zinc contributes to neurodegeneration, a process that can be prevented and even reversed by rapid chelation with zinc-specific reagents. This research program will supply tools for revealing the spatiotemporal distribution of mobile zinc, apply them to map its cellular sources and targets during electrophysiological and chemical stimulation in neural progenitor cells, live brain slices, and animals, and provide knowledge essential for the development of novel protocols and compounds to treat disorders stemming from mobile zinc dysregulation.